Planning to implement high-quality active surveillance in new-onset favorable risk prostate cancer

Project Summary
Many men with favorable-risk prostate cancer do not benefit from aggressive intervention. As a
preferred alternative, active surveillance is increasingly used to spare men from the potentially
significant morbidity of treatment. Although adoption of surveillance has increased over the last
decade, its implementation varies widely. Surveillance requires identification of patients with
indolent tumors, coupled with monitoring for changes in cancer severity. Unfortunately, insufficient
monitoring can render surveillance dangerous by exposing men to morbidity, and potentially
mortality, from avoidable cancer progression. Nearly all research related to surveillance quality has
focused on patient selection as opposed to implementation. Confirmatory testing within 6 months of
diagnosis, using prostate biopsy or MRI, is a key component to ensure appropriate selection, as
nearly half of men harbor more aggressive disease, albeit undetected, and may be better suited for
treatment. The Michigan Urological Surgery Improvement Collaborative (MUSIC) is a statewide
quality improvement collaborative consisting of 90% of all urologists in the state of Michigan and is
expanding outside the state. Among MUSIC urologists initiating surveillance, the use of
confirmatory testing in men with favorable-risk prostate cancer is only 61%. As there is strong
evidence that urologist and practice characteristics are associated with initiation of surveillance,
there is good reason to believe that these factors are also associated with use of confirmatory
testing and adherence to guidelines. The objective of this proposal is to design and develop
implementation interventions aimed at improving the quality of surveillance, and plan a large-scale
trial to test the implementation interventions with the following aims: 1) Assess the relative
importance of key implementation determinants; 2) Design and tailor interventions to support
implementation of quality surveillance in urology practices; and 3) Assess the value of including
practice sites beyond the original MUSIC sites in Michigan in the planned R01.

Public health relevance
Project Narrative This project will design and tailor interventions and develop plans for a large-scale trial to test these interventions to implement high quality active surveillance among men with favorable-risk prostate cancer. By identifying interventions to improve the quality of active surveillance, we will ensure its sustainability and protect against avoidable cancer morbidity. By focusing on scalable interventions, we will ensure that those developed can be implemented across large population groups.